Stanford Advanced Wound Care Center Clinical Research Unit

SUMMARY
Approximately 25% of diabetic patients experience diabetic foot ulcers (DFUs). This is a significant clinical
problem since there are no effective biomarkers for predicting outcomes, no drug candidates that have recently
been FDA-­approved and no therapies that are widely effective in treatment. The Stanford Advanced Wound
Care Center (AWCC) was opened in 2014 with the sole purpose of facilitating clinical trials, conducting
translational research and providing care for patients with chronic wounds. Stanford AWCC receives patients
from the University Healthcare Alliance, which spans 60 clinics and 2.5 million people in the San Francisco Bay
Area. Despite being in a relatively prosperous area, Stanford AWCC treats patients from diverse socio-­
demographics. In the past two years, Stanford has treated 6000 patients with wounds, of whom 705 had DFUs.
50% of the patients enroll in clinical trials and there is a very low dropout rate (less than 5%). Under Dr.
Geoffrey Gurtner’s leadership, the Stanford AWCC has conducted over 25 clinical trials, where we have
measured biomarkers and tested novel therapeutic interventions (Aim 1).

It is known that wound healing trials experience a significantly higher failure rate in Phase III studies compared
to any other drug trial. This is primarily due to the poorly controlled procedural component of wound care. At
Stanford, we address these issues by (i) practicing a multi-­disciplinary approach overseen by physicians, (ii)
standardizing the measuring and reporting of healing outcomes, (iii) emphasizing rigorous and efficient
operational processes during clinical trial conduct and (iv) collaborating with other major academic centers
(Aim 2). Looking forward, it is critical to optimize patient engagement during their treatment regimens and
inculcate a shared decision-­making process. Clinical studies in medical fields such as cancer have indicated
that such patient-­centered approaches lead to the adherence of treatment regimens and clinical trials. This is
currently lacking in with patients with DFUs. With Dr. Arden Morris’s expertise, the Stanford AWCC practices
new approaches that centers around the patient, with a focus on improvement in their quality of life (Aim 3).

Dr. Nigam Shah, the Director of Bioinformatics at Spectrum, Stanford’s Clinical and Translational Sciences
Award has worked with the Stanford AWCC and developed computational tools that predict wound healing
outcomes. These models have been developed using data from the Healogics database, the country’s largest
network of wound care clinics and a Stanford AWCC operational partner. Dr. Shah also has expertise in
analyzing electronic health records of patients from large databases such as TRUVEN and OPTUM, which will
allow for the determination of unique biomarkers for wound healing through computational modeling. These
models can be executed across the entire Diabetic Foot Consortium (Aim 4).

Public health relevance
Narrative The Stanford Advanced Wound Care Center (AWCC) was opened in October 2014 to fill both a clinical and academic need by integrating clinical trials and research in wound care. Since its launch, the number of patients with DFUs at Stanford AWCC has doubled in each of the past two years and the unit has been financially successful, ensuring its long- term viability. Here, we demonstrate the ability of Stanford AWCC to serve as a Clinical Research Unit (CRU) by displaying access to patients with DFUs from a wide sociodemographic, emphasizing quality of clinical research conducted, demonstrating ways of patient- centered collaborative decision making and using big data to accurately predict and quantify wound healing outcomes.